DLK1 as a novel target for Down syndrome myeloid leukemia

PROJECT SUMMARY
Down syndrome (DS), with triplication of chromosome 21, is recognized as one of the most important
leukemia-predisposing syndromes. 1-2% of DS children develop myeloid leukemia (DS-ML) before age 5,
which is preceded by a pre-leukemic phase termed transient abnormal myelopoiesis (TAM). 30% of TAM
cases progressing to DS-ML. Aside from low dose chemotherapy, there are no treatment options for TAM and
no preventative measures to stall DS-ML onset. Nearly 10-15% of children with DS-ML are either refractory to
treatment or suffer early relapse. These children with refractory disease face a dismal outcome with 3-year
event-free survival less than 21%. Moreover, treatment-related toxicity and morbidity is a major cause of death
in DS-ML patients. Therefore, novel therapeutic options are needed for this rare disease. Both TAM and DS-
ML are characterized by the pathognomonic mutation in the gene encoding essential hematopoietic
transcription factor GATA1, resulting in N-terminally truncated mutant GATA1 protein (GATA1s). Trisomy 21
and GATA1s are sufficient to induce TAM, while additional co-operating mutations in genes such as STAG2
are required for DS-ML leukemogenesis. The individual and synergistic contribution of these genetic events
towards DS-ML refractoriness and remodeling the bone marrow microenvironment remain poorly defined.
Using CRISPR/Cas9 mediated gene targeting for stepwise introduction of GATA1 or GATA1 and STAG2
mutations in iPSCs with trisomy 21, we modelled TAM and DS-ML respectively. We generated patient-derived
xenograft (PDX) models representing refractory DS-ML. Our transcriptome analysis to identify novel DS-ML
specific cell surface proteins revealed Delta-like non-canonical Notch ligand 1 (DLK1) as one of the top targets.
DLK1 transcript was undetectable in normal bone marrow specimens, while it was more abundant in DS-ML
compared to TAM. Enhanced expression of DLK1 was also detected in our iPSC-generated DS-ML models,
but not in TAM models. Our preliminary data shows that DLK1 knockout in DS-ML cell line suppressed
proliferation and delayed engraftment. Furthermore, targeting DLK1 via an immuno-conjugate significantly
reduced leukemic burden and prolonged survival in refractory DS-ML PDX lines. These results indicate that
DLK1 may promote DS-ML leukemogenesis and can be used as a therapeutic target. Consistent with the
effect of DLK1 on the inhibition of interferon signaling via suppression of NOTCH1 activity, we identified that
downregulation of DLK1 resulted in increased interferon signaling. Interestingly, we demonstrated that GATA1s
suppressed interferon signaling via downregulation of the RIG-I pathway in iPSC-derived TAM and DS-ML
models. Exogenous treatment of DS-ML cells with interferon-a resurrected interferon signaling, confirming that
the pathway is intact. Thus, suppression of interferon signaling via GATA1s and/or DLK1 is a DS-ML
dependency that can be exploited therapeutically. Upon study completion, we will identify novel treatment
options for TAM/DS-ML, and a newly characterized target that may also be exploited in non-DS leukemia.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE Chemotherapy-related toxicity and disease relapse with poor prognosis are the major impediments for a complete cure for Down syndrome associated myeloid leukemia (DS-ML). In this project, we propose different approaches to combat DS-ML. These approaches will provide a preclinically validated toolbox consisting of novel therapeutic options and combinations, not only for TAM/DS-ML, but also for other myeloid malignancies.